Models of Neuromodulatory Circuits in Drosophila

ABSTRACT
We propose to use a model circuit in Drosophila to study aminergic neuromodulation. The relatively small
number of presynaptic cells combined with easy access to both pre- and post-synaptic sites will allow us to
quantify the activity of each aminergic neuron, their functional relationships to post-synaptic targets and how
their activities are coordinated. Recently developed molecular genetic tools will allow us to map all of the
relevant receptors for the first time. New methods of preparing the tissue will allow us to identify the function of
both direct and indirect regulatory pathways. Using RNAi transgenes as well as classical mutations we will
define the function of all of the aminergic and glutamatergic receptors in the circuit and how they interact.
Preliminary Data have uncovered unexpected complexities in this relatively simple circuit that will be relevant
to a variety of other more complex circuits less amenable to the detailed analysis we propose here.

Public health relevance
Project Narrative We propose to use a simple circuit in Drosophila (the fruit fly) to determine how a neurotransmitter related to noradrenalin regulates intercellular signaling. The results will have broad relevance to more complex circuits that regulate mood, reward and attention.